IC-CSRisk Study: Implementation of Calculated Cesarean Section Risk during labor induction, a multi-site stepped-wedge randomized rollout trial

PROJECT SUMMARY
In the United States, over four million women give birth annually, with more than 20% undergoing labor
induction. One-third of inductions end in cesarean delivery, which are associated with increased maternal
morbidity. In the US, there are also significant, unacceptable disparities between Black, Indigenous, People of
Color (BIPOC) and non-BIPOC birthing people in cesarean rates and maternal morbidity. Outside obstetrics,
interventions that increase objectivity and decision-making standardization have been shown to limit the effects
of bias on health outcomes. In response, our group created a risk prediction model for cesarean among those
undergoing induction, which provides clinicians and patients with an individualized percentage risk of cesarean
for a given patient’s labor induction. In a single-site prospective cohort study, use of this cesarean risk
calculator was associated with substantial improvements in cesarean delivery rate and maternal morbidity.
Through mixed-methods work, we elucidated the calculator’s mechanisms of success: plausibly assisting
clinicians in objective decision-making, particularly for patients at very low or very high risk of cesarean,
The central hypothesis of this proposal is that, with a foundation in implementation science,
implementation of the cesarean risk calculator at diverse labor units across the US can have a profound impact
on critical obstetric outcomes for all birthing people, with a particular focus on patients of color. This proposal
leverages experienced investigators in maternal health equity (PI Hamm, Co-Is Levine, Howell, Clark, and
Hussey), implementation science (PI Hamm, Co-I Lane-Fall, Delgado, Stephens), biostatistics/epidemiology of
implementation (Co-I Stephens), and mixed methods (PI Hamm, Co-I Lane-Fall).
We plan to test our hypothesis by studying the effectiveness of the cesarean risk calculator, while
simultaneously collecting implementation data in a type I hybrid effectiveness-implementation, randomized
stepped-wedge rollout design across 14 committed labor units. Before the rollout begins, Aim 1 will evaluate
and catalogue contextual determinants at all included sites included in order to map implementation strategies
and workflow plans most likely to result in successful local implementation. Aim 2 will then determine
effectiveness of the cesarean risk calculator in the stepped wedge design, with planned stratified analysis by
patient race to evaluate calculator impact on disparities. Finally, Aim 3 will determine calculator acceptability,
penetration, and equitable reach in a mixed-methods approach.
By the conclusion of this work, we will have novel, clinically important information on the impact of the
cesarean risk calculator on labor outcomes, and an online toolkit for widespread implementation. The results of
this proposed R01 will also produce data generalizable to many future large-scale implementation endeavors
designed to improve maternal health.

Public health relevance
PROJECT NARRATIVE Cesarean delivery and maternal morbidity are at unacceptable rates in the United States, with profound racial disparities affecting each outcome. We propose to rigorously study use of a cesarean risk prediction calculator across 14 labor and delivery units as a means to reduce the cesarean and maternal morbidity rates, with a focus on improving health for birthing Black, Indigenous, and People of Color. In harnessing the innovative methodologies of implementation science into our study design, we will obtain the necessary data to enact our evidence-based intervention successfully at a national scale, a central mission of the National Institute of Child Health and Development (NICHD)’s Implementing a Maternal health and PRegnancy Outcomes Vision for Everyone (IMPROVE) Initiative.